Administrative Core

The overall management structure for the SBC will reside within the Administrative Core, which will provide organizational support for the entire Center and manage the day to day activities of the SBC. The Core will be staffed by a full-time Administrative Assistant who will take care of all of the day-to-day Center operations. A 50% assistant will provide administrative assistance to the EOC. Additionally the AC will be staffed by a Senior Administrator (10% time commitment) and Finance Manager (15% time commitment). The Senior Administrator will be in charge of monitoring the overall activities of the Center, Steering Committee, the Internal and External Advisory Committee meetings, maintaining the minutes of these meetings and ensuring that the actions mandated by these committees are implemented. The Finance Manager will be in charge of maintaining the budgets of the Cores and Research Projects. The key functions of the Administrative Core are summarized in the schematic in Figure 4. The AC will provide support for three types of activities: Meetings and Outreach The AC will organize the biweekly meetings of the Steering Committee, the monthly meeting of Center Investigators, the biannual meetings of the Internal Advisory Committee and the yearly external Advisory Committee. The AC will collect all the required Progress Reports and monitor all required compliance with institutional and NIH policies. The AC will be in charge of placing the advertisements for the Junior and Senior Visiting Fellows programs, collating the applications and distributing them to the Steering Committee for review. The AC will also assist the fellows in locating Mount Sinai housing and in travel arrangements. Educational Activities To support the educational activities The AC will also be in charge of organizing the Lectures, Journal Clubs and Research Colloquia, including sending out the invitations, developing and mailing the fliers and e-mail notices. The AC will also provide administrative support for the organization of the Workshop as well as the Symposium. Management and Finance The AC will provide support to manage the budgets of the various units located at Sinai and interface with the institutional authorities in participating institutions for units of the Center located outside. For all of the units located at Mount Sinai the AC will be responsible for placing orders for supplies, managing service contracts, etc.